Multidisciplinary Training in Molecular Endocrinology

Summary

This proposal requests continued support for the Molecular Endocrinology Training Program
(METP) at Vanderbilt University. Progress towards understanding and curing obesity, diabetes and
many other diseases requires the training of the next generation of scientists with expertise in
molecular endocrinology, the goal of this program. The METP comprises 30 faculty members from 6
basic science departments. Of this group 26 are established faculty with stable, well-­‐‑funded programs
and substantial training experience and 4 are new investigators; 3 of these preceptors are female, 2 are
minorities and 1 is disabled. This preceptor group constitutes an unusually diverse and talented group
of individuals whose work covers the spectrum of molecular endocrinology. These preceptors conduct
research in the general areas of: 1) signal transduction 2) the hormonal regulation of gene expression, 3)
metabolic regulation and 4) β cell development and function. The request for funding of a steady state
level of 8 predoctoral and 4 postdoctoral trainees is justified on the basis of the number, size and
quality of the research programs directed by the preceptors and the Institutional commitment to
continue the same level of trainee recruitment despite the tough economic climate. All METP trainees
are appointed upon the advice of a Steering Committee after being nominated by a preceptor.
Postdoctoral trainees have a Ph.D. degree. Rigorous in-­‐‑depth research training is the focus of both the
pre-­‐‑ and postdoctoral training programs. However, the METP also ensures that all trainees receive a
broad didactic education. Predoctoral training in the METP usually follows that received in the
Interdisciplinary Graduate Program (IGP). The IGP recruits almost all predoctoral trainees in the
biomedical sciences at Vanderbilt, provides a first year core curriculum, safety training and formal
evaluation and career counseling programs. This centralized recruitment has considerably increased
the number and quality of predoctoral students that enter Vanderbilt. After four laboratory rotations
predoctoral students choose a preceptor for their thesis project and compete for METP support. The
IGP and METP have been very successful in promoting diversity and both provide ongoing training in
the Responsible Conduct of Research. All METP trainees attend an annual METP Day retreat, a trainee-­‐‑
run data club and the Vanderbilt Diabetes Center (VDC) seminar series where they meet with visiting
scientists. In conjunction with the Juvenile Diabetes Research Foundation, the METP initiated a novel
strategy to increase the recruitment of disabled individuals, specifically undergraduates with type 1
diabetes, through the creation of a VDC-­‐‑funded Summer Diabetes Research Program. The METP has
already successfully trained 184 scientists of whom 85 have already gone onto assume
academic/pharmaceutical positions with another 49 trainees still in training.

Public health relevance
Narrative The field of molecular endocrinology is of central relevance to multiple common human diseases, most notably obesity and diabetes. Continued progress towards understanding and curing these and many other diseases requires the training of the next generation of scientists with expertise in molecular endocrinology, which is the goal of the Molecular Endocrinology Training Program (METP).